Breathing Research and Therapeutics (BREATHE)

PROJECT SUMMARY/ABSTRACT
We propose renewed funding of the Breathing Research and Therapeutics (BREATHE) Training Program at the
University of Florida (UF). This combined predoctoral and postdoctoral training program, which began in 2017,
is focused on the respiratory neuromuscular system, emphasizing discovery of new knowledge and its translation
to severe clinical disorders that compromise breathing capacity, stability and airway defense. In just over 4
years, with a “ramp-up” of 2 years, we established an internationally known training program with a “unique
focus, unlike any other” (quote from anonymous NIH reviewer); we are unaware of any other T32 with a similar
concentration on breathing and airway defense in traumatic, ischemic, infectious or degenerative clinical
disorders, despite their high cumulative prevalence and importance. Nine predoctoral and 7 postdoctoral trainees
have been funded through the BREATHE training program, including those supported by institutional match
funds; all graduates thus far have continued in academic, biomedical or research positions (eg. assistant
professor, clinical research director, K99 awardee, postdoc fellows, grant writer). We successfully recruited
demographically and scientifically diverse trainees (56% women, 31% underrepresented groups, 44% clinically
qualified, 19% engineering backgrounds). In this renewal application, we seek funds to continue building and
refining this unique program, with the goal of training the next generation of scientists devoted to preserving
and restoring breathing and airway defense in clinical disorders that most often end life by respiratory
failure. Our intent is to establish a cohort of respiratory scientists with diverse backgrounds capable of engaging
in basic discovery and/or clinical/translational research, with the necessary background and skills to work
independently and in interdisciplinary teams. BREATHE emphasizes training in respiratory neural and muscle
plasticity, and development of new therapeutic strategies to treat patients with compromised breathing capacity,
stability and/or airway defense. Our objectives are: 1) recruit a diverse cohort of high-quality basic science and
clinical predoctoral (3/year) and postdoctoral (4/year) trainees with an interest in breathing research and
therapeutics, and potential for independent research careers; 2) implement a carefully designed training program
that provides predoctoral and postdoctoral trainees with solid foundations in respiratory biology, airway defense
and translational research, and the technical, analytical and professional skills necessary for productive research
careers; and 3) foster an interdisciplinary, collaborative research environment conducive to preparing scientists
for successful careers in interdisciplinary research. The UF environment includes collaborative faculty mentors
with diverse and complementary expertise, state-of-the-art facilities, ongoing translational research partnerships
and a rich menu of career development opportunities. Our renewal application builds on proven elements, with
an emphasis on being responsive to the rapidly changing landscape of respiratory research.

Public health relevance
PROJECT NARRATIVE Although diminished breathing capacity and airway defense undermine the quality and duration of life in virtually all neuromuscular disorders, such as spinal injury, ALS, Pompe disease, muscular dystrophy and Parkinson’s disease, few biomedical researchers have the expertise and translational perspective needed to develop new treatments that preserve or restore the ability to breathe and defend the airway. This renewal application seeks continued funding to train pre- and postdoctoral fellows with basic science, clinical or engineering backgrounds to fill this critical need. Trainees from diverse scientific backgrounds will develop a solid foundation in the respiratory biology, airway defense, translational research and technical/analytical skills needed for productive careers in breathing research and therapeutics.